User Training and Outreach Component

The primary goals of the GM/CA@APS Training and Outreach Core are to train users about the advanced
technologies offered by the GM/CA macromolecular crystallography resource and to reach out to the
scientific community with information about GM/CA technologies. Dr. Janet Smith (PI) leads the Training
and Outreach Core; most GM/CA staff have roles in one or more aspects of training and outreach.
Training of both remote and on-site users is achieved through personal interactions with GM/CA staff
hosts and through videos and documentation available at the GM/CA website. The on-line materials will
be updated frequently to keep pace with the growing sophistication of the JBluIce user interface and the
associated data processing pipelines. To provide improved training for remote users, who are the majority
of the GM/CA user base, we will develop a reverse-remote access program in which GM/CA staff travel
to user labs at locations where there are several user groups and provide hands-on training during user
beam time. We will continue to host the successful annual CCP4/APS School for Macromolecular
Crystallography, now in its twelfth year, and to teach the data collection section of the School. An
important goal is to reach out to the user community with information and training about the new
capabilities that will be available with the upgraded APS (APS-U) with its 100-fold brighter beam. We will
develop training materials and workshops to prepare for the exciting new opportunities with APS-U. We
will continue general outreach to the scientific community through staff attendance and presentations at
scientific conferences. We will also promote the GM/CA Resource by highlighting significant user results
through our website and the APS and Argonne communications offices.
1